Path C ADAI will continue to maintain a produce safety regulatory program to encourage the safe production of covered produce while using Path C as a guide to complete all objectives specified.

Program Summary
The Alabama Produce Program will not only help to sustain the produce industry but will assist
Alabama producers in growing the industry in the face of regulations and evolving market
expectations by aiding produce farms of all sizes and stages of development to meet food safety
requirements, access markets, and promote public health as sustainable agricultural businesses.
By focusing on outreach and education, technical assistance as well as compliance, our program
will assist all growers to adopt and implement on-farm food safety practices, furthering the
Food Safety Modernization Act's vision of preventing foodborne illness.
Continued assessment of the produce landscape in Alabama while focusing on produce covered
under the PSR and determining continued need of resources will be instrumental incontinued
implementation of the produce program. With farm inventory being the basis for the program
planning, establishing a complete and accurate inventory of produce farms will assist in
implementing corresponding objectives inthe CAP program.
Maintaining the current inspection program inplace so that ADAI is working together with all
produce programs nationwide in an integrated way to achieve our public health goals. By
working together nationally, ADAI will focus on quality and consistency in developing and
updating SOPs related to inspection program. ADAI will work to prioritize inspections
according to produce safety inspections assignment by using the PDAT tool and 'WinWam
software to pull the data needed to prioritizing inspections.
Continued development of ADAls compliance and enforcement program will be tailored to
Program Path C and the objective guidance provided by FDA. ADAI will utilize written procedures
for conducting compliance and enforcement activities that establish a risk-based process to
determine when a directed investigation, follow-up or re-inspection is needed. Framework for
compliance and enforcement progressive actions will be achieved by utilizing the current
compliance and enforcement guidance available.
Development of the ADAI Produce Safety Program will involve a multi-year process. It is
recognized by the Food Safety Division that developing a new Produce Safety Program and
achieving alignment with the Produce Safety Rule will require a further comprehensive self--
assessment and will involve efforts to focus on continuous program improvement and
innovation throughout and well beyond this 5-year grant period.

Public health relevance
PROJECT NARRATVE The Alabama Department of Agriculture and Industries (ADAI) will continue to maintain a produce safety regulatory program that addresses the growing, packing, harvesting, and handling of produce grown on farms. ADAI will continue to encourage the safe production of covered fruits and vegetables and promote understanding and compliance with the FDA’s Produce Safety Rule through education, outreach, technical assistance, and training. By continuing these practices, ADAI is confident there will be less foodborne illness outbreaks nationwide traced back to raw produce grown in the state of Alabama as well as for Alabama residents consuming locally grown produce that is safe to eat.